Preclinical Therapeutics Shared Resource

Preclinical Therapeutics Shared Resource: Summary/Abstract
The goal of the Preclinical Therapeutics Shared Resource (PCT) is to provide streamlined in vivo preclinical
therapeutic services and training to HDFCCC members. The PCT uses state-of-the-art rodent cancer models,
therapeutic delivery modalities, and live imaging technologies to facilitate generation of high-quality data that
may be translated into clinical oncology research. The PCT facilitates translational research by providing a full
suite of in vivo rodent services to HDFCCC investigators. The PCT ensures a stable infrastructure for small
rodent cancer studies within a specific pathogen-free (SPF) barrier, facilitating rigor and reproducibility, cost-
effectiveness, and quality control.